ND INBRE Health & the Environment

Abstract
A major contributor to health inequities is the lack of a diverse biomedical research workforce that is
technically proficient in data management, computer programming, and analytics as well as the ability
to work effectively on interdisciplinary teams. This skillset in data science is essential for advancing
knowledge of factors that drive disparities using a wide array of data sources and for leveraging
information that leads to improved clinical decision-making and the public health of tribal communities.
Tribal colleges and universities (TCUs) historically have played a pivotal role in preparing students for
STEM-related fields that address local workforce needs. (NAS Town Hall, 2021) However, none of the 5
TCUs in North Dakota offer courses or specialized training in biomedical or health data science despite
the need for this expertise in tribal health organizations. In the last funding cycle, the ND INBRE began
to address this gap in data science education by developing the VIDS Academy, a 5-day intensive
introduction to data science for American Indian undergraduates at the 5 TCUs in ND. The VIDS
Academy is schedule for July 2022 and 30 students have registered for the course. In this present
proposal, the major goal is to develop the academic resources for the development of data science
within the tribal communities and to form collaborations with UND that will encourage American Indian
undergraduates to pursue the baccalaureate degree in data science and possibly post-baccalaureate
training in data science. The UND SMHS welcomes the opportunity to participate in “The Virtual IDeA
for Data Science Education (IDSE) Program”.

Public health relevance
Narrative Data science is essential for advancing knowledge of factors that drive disparities using a wide array of data sources and for leveraging information that leads to improved clinical decision- making and the public health of tribal communities.